SEER CCDI-LINKED PEDIATRIC CANCER WHOLE SLIDE IMAGING PILOT- UNIVERSITY OF CALIFORNIA, SAN FRANCISCO

: Automated digital imaging analysis of whole slide images of microscopic slides offers an exceptional opportunity to assist in, and thereby streamline, the histomorphologic assessment of tumors that can be used in studies of diagnostic accuracy, cancer outcomes, and treatment response. An integrated system of whole slide imaging (WSI) linked with cancer registry data would support population-based cancer research, leveraging the recent and ongoing technological advances in imaging, clinical, and outcome data may ultimately yield important insights in improving the care of cancer patients.